Long-term effects of wildtype huntingtin lowering in the primate corticostriatal tract and thalamus

PROJECT SUMMARY / ABSTRACT
Most huntingtin-lowering treatments in development or clinical trials are not selective for the mutant allele, but
also lower wildtype huntingtin expression. The purpose of this project is to fill critical gaps in our knowledge
about the effects of wildtype huntingtin lowering in the primate brain over an extended period of time in brain
regions relevant to Huntington’s disease (HD) and to the functions of wildtype huntingtin. Data from mouse
models of HD indicate that lowering huntingtin in cortical neurons that are part of the corticostriatal system may
be necessary for optimal therapeutic efficacy.1-3 Although prior research has established that lowering wildtype
huntingtin by 45% in the primate striatum is well-tolerated for six months,4 this and other research5 has not
lowered wildtype huntingtin in primate corticostriatal neurons whose axons comprise the corticostriatal tract.
Huntingtin is involved in the rate of production6 and transport7 of BDNF (brain-derived neurotrophic factor) from
cortical neurons to the striatum, on which striatal neurons depend.8 It is unknown whether reduction of wildtype
huntingtin in corticostriatal neurons/tract of the primate brain will adversely affect the survival and functioning of
striatal neurons. AIM 1 will assess the long-term tolerability of wildtype huntingtin lowering in the corticostriatal
tract over 9 months by quantitatively measuring the effects of this lowering on locomotor activity, BDNF levels
and neurotransmitter systems. As research tools, the project uses an shRNA already known to lower huntingtin
in the primate4 and a serotype of AAV already known to retrogradely transduce cortical neurons from a striatal
point of infusion.9 Treatment of the thalamus has been proposed as a means of enhancing vector distribution in
the brain16. However, pathologic calcification of the thalamus has been reported in mice 9 months after partial,
conditional knockout of wildtype huntingtin.10 AIM 2 will determine if reduction of wildtype huntingtin in the
primate thalamus will result in an increased thalamic calcium accumulation, whether occurring incidentally from
striatal infusion of vectors or directly by vector infusion targeting the thalamus. In the proposed studies, thirty-
two (32) adult rhesus monkeys will be equally divided into four experimental groups (N= 8 animals/group) and
randomly assigned to receive MRI-guided injections of AAV6 encoding a huntingtin-lowering shRNA or a
control shRNA, directly into either the striatum (AIM 1) or thalamus (AIM 2). Monkeys will be assessed by
periodic behavioral and neurological exams. In vivo glutamate signaling in the cortex, striatum and thalamus
will be assessed 9 months after AAV administration. Post-mortem analysis will include assessments of
dopamine turnover and BDNF levels in striatal tissue as well as calcium in the thalamus and neuropathological
evaluations of coronal brain sections, including cortex, striatum and thalamus. The data obtained by this
project in the nonhuman primate will provide information that cannot be readily obtained from human clinical
trials of huntingtin-lowering treatments. This information will be pertinent to any current and future therapies for
HD that use non-allele-specific means to lower huntingtin irrespective of the agent or route of delivery.

Public health relevance
PROJECT NARRATIVE Treatment of the cortex as well as the striatum may be desirable for optimal efficacy of a huntingtin-lowering treatment for Huntington’s disease, but lowering huntingtin in the cortex may affect underlying neurotransmitter systems and/or reduce the transport of trophic factors from the cortex to the striatum that are necessary for the survival and function of striatal neurons. The thalamus is also a potential therapeutic target, but reduction of huntingtin in the thalamus causes pathologic calcification in mice and it is unknown whether this might also occur in the primate brain. The purpose of this project is to fill critical gaps in our scientific knowledge about the effects of lowering huntingtin protein expression in the corticostriatal connections and the thalamus of the primate brain, to provide useful information for current and future generations of huntingtin- lowering therapies for Huntington’s disease.